Ancestry-Specific Genetic Influences and Potential Therapeutics for Ocular Disorders in the Million Veteran Program

Background and Innovation. The ability of Veterans to retain independence depends
on their ability to perform visual tasks such as reading and driving. This independence is
threatened by ocular disorders such as age-related macular degeneration (AMD) that
result in central vision loss and are prevalent in the Veteran population. We currently lack
a complete understanding of the risk factors that contribute to AMD onset and the basis
for their marked variation between Veterans of European (EUR) or African (AFR)
ancestry. Currently, we have insufficient treatment options to offer Veterans with AMD to
slow or stop disease progression and vision loss. The VA Million Veteran Program (MVP)
provides a powerful resource to address these shortcomings, by providing genetic data
in the context of the de-identified but otherwise complete electronic health record (EHR)
and other MVP-specific instruments (e.g., lifestyle survey). MVP is one of the largest
biobanks in the world, with more than 1 million Veterans having been enrolled to date.
Importantly, MVP has enrolled substantial numbers of Veterans of AFR and EUR
ancestry, providing the opportunity to follow on our original observation that genetic
variants that confer strong risk in EUR populations do have a comparable impact on
individuals of AFR ancestry. MVP now provides whole genome sequence data for a
considerable number of Veterans, which provide a critical next step to understand
ancestry-specific differences in AMD risk. Aim 1 will use these to data to understand
observations made during the current award period that alleles for genes such as CFH,
which make strong contributions to risk for age-related macular degeneration (AMD) in
EUR cohorts, are not linked to AMD in AFR populations. In Aim 2 we will use the MVP
EHR data to determine if drugs already used in the care of Veterans impact AMD risk.
We will follow our proven model wherein we documented that metformin decreases risk
for AMD in both EUR and AFR Veterans.
Significance and Impact to Veterans Healthcare. This project will (a) identify risk
factors that drive AMD pathogenesis in diverse populations, thereby providing tools for
early identification of the disease state based on EHR and genetic data and (b) identify
medications already in the VA formulary that impact AMD risk.
Path to Translation/Implementation. This project will provide a roadmap for early and
effective diagnosis across the diverse ancestries that comprise the U.S. Veteran
population. This project will provide insights into new therapeutic approaches for AMD,
which can be rapidly incorporated into future clinical trials.

Public health relevance
Age-related macular degeneration (AMD) impairs Veteran’s ability to conduct important activities of daily living (reading, driving) and to operate independently. The factors that underlie AMD are incompletely understood and only limited treatment options are currently available. In our prior work using the VA Million Veteran Program (MVP) biobank we noted marked differences in genetic risk between Veterans of European as compared to African ancestry. A major purpose of this project is to clarify the basis for this difference. A second purpose is to determine if drugs already in use by the Veterans Health Administration impact disease risk. This project will utilize the vast resources provided in the MVP to address important knowledge gaps and thereby make a long-term contribution to our understanding of AMD.